Cognitive decline among WTC survivors with chronic mental and physical disorders

Project Summary
The World Trade Center Environmental Health Center (WTC EHC) is a NIOSH-designated treatment and
monitoring program for community members (“WTC Survivors”) with acute and/or chronic WTC exposures.
Physical exposures include acute exposures to the massive dust clouds from the collapsing WTC buildings as
well as chronic exposures to the resuspended dust and fumes in the subsequent months. Many also had
traumatic psychological exposures as they witnessed death and dismemberment, worried about their own
safety, lost their livelihood, or were displaced. There is a high prevalence of post-traumatic stress disorder
(PTSD), chronic pulmonary disorder, and many types of cancers among WTC Survivors. Enrollees of WTC
EHC include about 50% women and have diverse social-economic and racial/ethnic backgrounds. The WTC
dust and fume exposures have been shown to be associated with mental-physical disorders, including PTSD,
respiratory disorders, and cancers. Importantly, increased cognitive impairments have recently been
extensively studied and widely reported for WTC responders; however, little is known for WTC Survivors. We
hypothesize that the oxidative stress from the WTC exposures and affiliated systemic inflammation are part of
the biological mechanism underlying the comorbid mental and physical disorders and contributing to
neuroinflammation, neurodegeneration, and cognitive impairments in many WTC Survivors. To date, the
biological mechanism underlying the WTC exposures, prevalent comorbid mental and physical disorders, and
cognitive impairments and decline over time have not been investigated in WTC Survivors, leading to
knowledge gaps and considerable uncertainty in both diagnosis and assessment of health disorders for
Survivors. To improve diagnosis and treatment and to identify the biological underpinning of these health
disorders, we propose a longitudinal study to assess cognitive functions and rate of changes over time among
WTC Survivors enrolled at WTC EHC and also measure blood-based biomarkers of systemic inflammation,
neuroinflammation, and neurodegeneration. We will conduct causal inference to analyze existing patient-level
WTC exposures and comorbid mental-physical disorders data together with newly obtained cognitive scores
and blood-based biomarker data to assess the effect of comorbid conditions and inflammation and
neurodegeneration biomarkers in blood as mediators of the WTC exposures for cognitive impairments and
cognitive decline over time both in the whole study population and in vulnerable subpopulations. The study
aims to understand the biological mechanisms of how complex WTC exposures affect comorbid mental and
physical disorders and impact cognitive dysfunctions in WTC Survivors. Completing this project may lead to
the identification of novel blood-based biomarkers for non-invasive accurate disease diagnosis and cost-
effective monitoring as well as potential targets for effective intervention.

Public health relevance
Project Narrative There is a high prevalence of post-traumatic stress disorder (PTSD) and chronic lower respiratory symptoms among community members affected by the September 11, 2001 terrorist attack on the World Trade Center (WTC) towers (“Survivors”). Despite widely reported cognitive impairments among WTC Responders, there is a lack of information about cognitive status among WTC Survivors and there is a lack of knowledge about the association between WTC exposures, chronic PTSD, severe lung disorders, cognitive status, and cognitive decline over time. To improve diagnosis and treatment and to identify the biological underpinning of the health disorders, in this project we propose to investigate the biological mechanisms linking WTC exposures, comorbid PTSD and severe lung disorders, with cognitive function or decline by assessing the effect of inflammation and neurodegeneration biomarkers in blood as mediators of WTC exposures and risk of cognitive abnormality and as possible modifiable targets for interventions.